CORE--FLOW CYTOMETRY

The Flow Cytometry Shared Resource provides Cancer Center members doing both basic research and clinical studies with the opportunity to measure a wide variety of cellular parameters such as: antigen expression/quantitation, DNA content/cell cycle status, reporter gene expression and functional attributes of cells (i.e. Intracellular pH, Ca++ flux, redox status, membrane potential, etc.). Because these parameters are measured on a single cell basis, one can determine population heterogeneity as well as physically sort out cells of interest- based on their expression of any of the above parameters-for further investigation. These capabilities allow the precise characterization and isolation of cells from in vitro experimental protocols or from patient specimens, so that they can be further studied in the research laboratory. In addition to providing direct cytometric services, the facility also provides training for students, technologists, fellows and principal investigators in the use of flow cytometry (both from the theoretical standpoint and in the actual operation of the equipment). The Facility Supervisor provides consultation to Cancer Center members who are designing experiments or proposing the use of flow cytometry in a grant application. The facility is staffed by a director and two technologists, providing full service Monday through Friday. Additionally, individuals trained to operate the equipment themselves have access to the facility at any time, 7 days a week.